Reproductive Sciences and Genomics Training Program

[unreadable] DESCRIPTION (provided by applicant): The overall goal of the proposed Program is to provide comprehensive and in-depth research training in the reproductive sciences centrally integrating training in the tools of functional mammalian genomics and genetics. To accomplish this goal, a select group of graduate and postdoctoral trainees will have the opportunity to choose and be trained by dual mentors; the primary trainer having expertise in the reproductive sciences and the co-trainer with expertise in genomics. Nineteen faculty trainers are represented in this application. We are requesting support for three baccalaureate Ph.D. slots and two postdoctoral slots, each for a 2 year training interval. Support is requested for a total of 5 years for this new Training Program. The philosophy behind this proposed training plan is based upon the appreciation that biomedical researchers in the reproductive sciences would benefit greatly from parallel training in practical and applied use of genome-wide investigative techniques. Cornell University is uniquely poised for a training program in reproductive sciences that spans male and female physiology, the genetic bases of fertility, the immunological basis of the maternal-fetal interface, cell signaling and molecular endocrinology and the molecular and genetic basis for reproductive cancers. In addition, the proposed Program will benefit greatly by inclusion of faculty members with interests in non-mammalian models of reproduction in Drosophila and C. elegans to facilitate comparative evolutionary studies. Training in the genomics area will emphasize the following (some examples): creation and use of transgenic and knock out models (animal models for the study of fertility as well as models of disease pathophysiology emphasizing reproductive neoplasia); use of micro arrays and bioinformatics analyses including comprehensive training in manipulation of databases for model organisms and genomic browsers/portals that serve to aid in determination of genotype/phenotype relationships; creation of computer-based modeling to facilitate informed decisions on structure/function relationships; analysis of gene transcription networks based upon application of principles of comparative genomics. The faculty members involved in this proposed Program are committed to facilitating a training environment in the reproductive sciences and its interface with genome structure and activity. The collaborative effort(s) between trainers and co-trainers is the cornerstone of this Program. This unique scientific and technical interface will enhance the opportunity for pre- and postdoctoral trainees to leave this environment well-trained in the reproductive sciences and in multiple state-of-the-art techniques and applications in genomics that will optimize their continued success in continued training (transitioning to postdoctoral) or the acquisition of scientific positions in academia, government or industry. [unreadable] [unreadable] [unreadable]